Pathways Linking Early Adversity and Support to Behavioral and Physical Health

PROJECT SUMMARY
The destructive effects of early adversity, such as chronic poverty and child maltreatment, substantially
increase the risk for mental and physical health disorders across the lifespan. Understanding theoretically-
informed mechanisms through which child adversity eventuates in psychopathology and poor physical health
as well as the processes that may ameliorate those toxic effects, are top public health priorities. There is a
significant gap regarding prospective, longitudinal research that delineates how adversity “gets under the skin”,
as well as processes that may protect children from early adversity. Informed by the Ecological-Transactional
Model of Child Maltreatment and the Biological Embedding of Child Adversity Model, the current project aims
to 1) prospectively examine the potentiating effect of early adversity on children's psychological and physical
health; (2) understand mechanisms linking adversity to child health, with a focus on parent regulatory
processes (psychopathology, cortisol), and children's behavioral (EF, emotion regulation, effortful control,
lability), and biological regulation (cortisol, inflammation); and (3) evaluate the role of caregiving support on
child health outcomes as a function of a parenting intervention that increased maternal support. To accomplish
these aims, we will assess mother-child dyads (N = 240) who previously participated in a longitudinal
randomized clinical trial (RCT) of a parenting intervention for maltreated preschool-aged children and their
mothers, Reminiscing and Emotion Training (RET). Maltreating families were randomized into the RET
condition or a Community Standard (CS) case management condition. A comparison condition of
demographically matched nonmaltreating families (NC) was also included. All children had experienced
significant adversity between ages 3-6, when enrolled. In the current proposal, 240 families will participate in
two new follow-up assessments, one year apart, when children are ages 8-11. The multi-method, multi-
domain battery includes assessment of adversity and child maltreatment, child behavioral and biological self-
regulation, maternal regulation, maternal and alternate caregiver support, and child psychological
(internalizing, externalizing) and physical health (metabolic risk). Preliminary evidence indicates that the RET
intervention improved maternal support; thus, our design provides a unique opportunity to experimentally
evaluate the protective role of caregiving support on children's self-regulation and physiology, and whether
relational interventions may improve physical as well as mental health. Overall, the results may have
significant implications for intervention science, public health, and social policies designed to reduce the
burden of mental and physical health problems among children exposed to early adversity. Moreover, it will
advance our theoretical model by delineating specific mechanisms associated with the cascading influence of
early life adversity and maltreatment on child behavioral and physical health outcomes, as well as establishing
a key modifiable process that may ameliorate negative effects via the RET intervention.

Public health relevance
PUBLIC HEALTH RELEVANCE: The proposed project has significant implications for public health and developmental psychopathology by examining how early child adversity affects mental and physical health, and by identifying modifiable targets for intervention and prevention programs for children exposed to poverty and child maltreatment. This project will: (1) prospectively examine the potentiating effect of early adversity on children's psychological and physical health; (2) evaluate theoretically-informed explanatory mechanisms linking adversity to child health at multiple levels of analysis, with a focus on behavioral and biological self- regulation of the parent and child; and (3) experimentally evaluate the protective effects of maternal support on child health outcomes as a function of a parenting intervention. The project is relevant to the priorities identified by NICHD's Social and Emotional Development/Child and Family Processes program by examining the psychosocial and psychobiological mechanisms through which child adversity eventuates in psychopathology and physical diseases, as well as the processes that may ameliorate those toxic effects. .